Defining the conformational control of nitric oxide synthases by a multipronged approach

PROJECT SUMMARY
The parent award is on deciphering conformational dynamics of nitric oxide synthase proteins through an
integrated approach using advanced spectroscopic techniques. Fourier transform infrared (FT IR)
spectroscopy is essential to the proposed studies of short-range conformational sampling (Aims 2 and 3) in the
parent project. Here, we request funds to purchase a state-of-the-art Bruker VERTEX 80 FT IR spectrometer to
enhance our IR research capabilities. Combining high sensitivity, resolution and speed with enhanced
expandability and easy-to-use FT IR software, the VERTEX 80 system is the answer for demanding protein IR
research. The high-performance research-grade instrument is designed to be top of the line. The superior
capabilities of the system will be necessary for our efforts to develop and optimize our workflow and methods
for site-specific IR spectroscopic investigation of local protein dynamics. Our findings will greatly benefit other
investigators using IR methodologies for large, complex proteins. Therefore, the requested equipment will help
the parent project to exert a sustained, powerful influence on the research fields of biophysics and bioinorganic
chemistry. Moreover, the administrative supplement will enhance the scientific environment for NIH-funded
investigators at the University of New Mexico, both within and outside of the College of Pharmacy. To our
knowledge, no comparable instrumentation exists in educational institutions within the region. Dean Godwin
has committed substantial financial support to this supplement request since this is a great investment for the
College. Taken as a whole, the proposed supplement will increase the parent award’s overall impact within the
original scope and bolster research quality and depth at our institution.

Public health relevance
PROJECT NARRATIVE The nitric oxide synthase (NOS) family is an important target for development of new drugs for severe diseases that currently lack effective treatments, including stroke and Alzheimer’s. It is essential to define the short-range NOS protein dynamics by site-specific infrared (IR) spectroscopy. To enhance and expand our IR protein spectroscopic capabilities, we will install a Bruker VERTEX 80 FT IR instrument.